Direct Proteolytic Machine Assessments for Unfolding and Sequencing Proteins

Project Summary
Protein sequencing is a cornerstone of proteomics, offering crucial insights into the molecular underpinnings of
biological processes and diseases. However, current proteomic tools, such as mass spectrometry (MS),
immunoassays, and protein cataloging approaches, are limited by high costs, low throughput, and an inability to
perform comprehensive de novo protein sequencing. These limitations hinder the accurate characterization of
low-abundance proteins and the sequencing and quantification of post-translational modifications (PTMs), single
nucleotide polymorphisms (SNPs), and splicing variants, making proteome-wide analysis challenging. Given
these constraints and the growing demand for more comprehensive proteomic analysis, there is a significant
opportunity to develop more efficient, cost-effective, and scalable protein sequencing methods. In response,
Electronic BioSciences, Inc. (EBS) proposes to develop and demonstrate a novel enzyme-based, single-
molecule protein sequencing system. This innovative platform will leverage enzyme-driven processing and
sequencing of individual proteins and peptides, combined with advanced bioinformatics, to achieve high
accuracy and throughput. During this Phase I program, we will develop and optimize this single-molecule
sequencing approach, demonstrating its ability to accurately sequence peptides with various PTMs, surpassing
the capabilities of current state-of-the-art methods. By integrating enzymatic assessments with sophisticated
sequencing algorithms, our system aims to enable scalable, multiplexed protein sequencing, capable of
analyzing all proteins and peptides in a given sample. Our proposed system will not only be rapid, reliable, and
low-cost but also accessible for a wide range of applications, from basic research to clinical diagnostics. This
technology has the potential to revolutionize protein analysis, facilitating rapid biomarker discovery and
enhancing disease testing and monitoring, ultimately advancing biomedical research and public health.

Public health relevance
Project Narrative This project aims to develop a novel enzyme-based, single-molecule protein sequencing platform that will provide a cost-effective, high-throughput solution for comprehensive proteomic analysis. By enabling the accurate sequencing of proteins, including those with post-translational modifications, this technology will significantly advance research capabilities and clinical diagnostics. Ultimately, this platform has the potential to improve public health by facilitating early disease detection and personalized treatment strategies.